Homeobox Genes and Neuron Identity Control on a Brain-Wide Level

PROJECT SUMMARY
While common, evolutionarily conserved themes of early neuronal patterning in the developing
embryo have emerged over the years, there are, as of now, no firmly proven, common organizational
themes for how neuron acquire and maintain their terminally differentiated state. We propose to
probe here existence of such a common organizational principle, by testing the hypothesis that each
neuron class of the nematode C. elegans is functionally specified by members of a specific family of
transcription factors, the homeodomain-type transcription factors. We test this hypothesis by using
rigorous genetic loss of function analysis, using mutant alleles of all 70 conserved homeobox genes
and using a multicolor bar coding scheme, through which we visualize the differentiated state of all
neurons throughout the nervous system. The finding that homeodomain transcription factors control
the identity of all neurons in a simple nervous system would have wide-ranging implications for our
understanding of evolution of the nervous system and may provide explicit directions for how to
classify and then functionally study neuron classes in mammalian nervous systems.

Public health relevance
PROJECT NARRATIVE Our aim is to explore unitary principles of nervous system development. Using a simple invertebrate model system as a test case, we test here the hypothesis that an evolutionarily conserved class of transcription factors, called homeobox genes, are key specifiers over neuronal identity throughout the entire nervous system of an animal.